COMMUNITY ENGAGEMENT

The Center for Integrative Environmental Health Sciences (CIEHS) will promote the translation of research on
pollution and lifestyle factors to understand their role in human health and diseases. The CIEHS Community
Engagement Core (CEC) vision is to develop and sustain community-academic partnerships that enhance the
health of south-central and western Kentucky residents by empirically addressing pollution and lifestyle factors
influencing chronic diseases. The aims of the CEC are to: (1) facilitate and support multi-directional
interactions among residents, community agencies and the CIEHS to assess community needs and priorities;
(2) facilitate and support multi-directional interactions to increase community awareness and understanding of
CIEHS research and resources; 3) cultivate environmental literacy among identified audiences; and (4) build
capacity for community-led and community-engaged environmental health research. The approach to engage
the identified audiences has three tiers: (1) engage community residents via housing agencies to assess
environmental health needs and community priorities; (2) involve healthcare providers to impact the healthcare
system as it relates to environmental health needs; (3) share environmental health knowledge with community
youth as a catalyst to promote environmental health literacy within families. In Aim 1, the CEC will work directly
with residents and community partners across south-central and western Kentucky to assess their unique
community needs and priorities. Based upon the needs identified, the CEC will translate and disseminate
environmental health information to our targeted audience, including CIEHS research findings (Aim 2). We will
communicate with communities using multiple traditional (e.g., newspapers, factsheets) and non-traditional
formats (e.g., social media platforms). With Aim 3, the CEC will leverage its community engagement efforts to
increase environmental health literacy in a three-tiered, staggered approach in the four University of Louisville
Area Health Education Center (AHEC) regions of south-central and western Kentucky. Outreach and
engagement efforts will involve community members, healthcare providers and community youth. Established
resources from the EPA and NIEHS will be accessed, including the Partnerships for Environmental Public
Health. In Aim 4, the CEC will collaborate with the Pilot Projects Program, the Stakeholders Advisory Board
and other community organizations to develop and implement, through the Integrated Health Sciences Facility
Core (IHSFC ), community-led environmental health research. Aim 4 will also include working closely with the
IHSFC to facilitate investigator-initiated, community-engaged environmental health studies. The four targeted
UofL AHEC areas include smaller urban areas, multiple townships, and rural areas. Residents in these rural
areas are exposed to diverse environmental exposures from industry (e.g., rural distilleries; urban/small
town/rural manufacturing), 12 superfund sites, and urban and rural agriculture. The CEC is an integral core
within the CIEHS structure with direct impact on CIEHS research direction and decision-making.